Improving Access to Alzheimer's disease and Related Dementias care services for Latinx individuals at Community Health Clinics. A multiphase mixed methods study.

PROJECT SUMMARY/ABSTRACT
Latinx individuals are 1.5 times more likely to develop Alzheimer's disease and related dementia
(ADRD) than non-Latinx White adults. However, compared with non-Latinx Whites, they are less
likely to receive a diagnosis, and when they do, they are more likely to be at late stages in the
disease process. This is a result of individual and contextual factors that limit access to health
care services in older Latinx adults, resulting in worse health outcomes for patients and caregiv-
ers. To improve access to care for Latinx individuals, it is necessary to account for Latinx individ-
uals' diverse backgrounds and socioeconomic characteristics, and develop innovative interven-
tions that are feasible to implement in underserved areas. The proposed K99 phase includes
training to fill my gaps in knowledge—the organizational factors affecting access to ADRD
healthcare services, the use of behavior change theories and design thinking in health interven-
tions, and the conduct of pragmatic trials in ADRD research. The overarching objective of this
proposal is to increase access to culturally appropriate ADRD services by performing a compre-
hensive assessment of the barriers existing at five locations in the US and engaging a team of
stakeholders in a human-centered process to develop a systems-level intervention for increasing
access to ADRD services. To achieve these goals, we propose a multiphase mixed methods
research process. Aim 1 (K99 Phase) includes the validation of a survey instrument that measures
beliefs that affect intentions to seek care for cognitive symptoms. This instrument will be an im-
portant tool to describe the individual beliefs that sustain health disparities in subsequent stages.
Aim 2 (K99-R00 phase) includes partnering with five (5) community health clinics in different cities
around the US to characterize the individual and contextual factors that affect Latinx access to
ADRD healthcare services. For this, we will use the BESIC instrument to describe beliefs among
Latinx patients, hold five focus groups with Latinx patients with ADRD and their caregivers, and
conduct up to 50 interviews with key informant stakeholders. Aim 3 (R00 Phase) will involve part-
nering with one community health clinic to co-design a human-centered intervention for promoting
Latinx access to healthcare services for ADRD. At the conclusion of this project, we will have a
validated survey instrument to assess ADRD beliefs linked to health care seeking behaviors in
heterogeneous Latinx populations and a prototype of an intervention to increase access to ADRD
services. Future studies will pilot the intervention and subsequently evaluate its effectiveness us-
ing an embedded pragmatic trial.

Public health relevance
PROJECT NARRATIVE Latinx individuals are 1.5 times more likely to develop Alzheimer's disease and related dementias (ADRD) than non-Latinx whites, and have higher rates of under-diagnosis. As the proportion of US Latinx older adults is expected to increase five-fold over the next 30 years, it has become obvious that they experience unique barriers to access ADRD care services. This proposal seeks to perform a comprehensive assessment of the barriers experienced by Latinx individuals, and co-design with stakeholders a human-centered intervention that can increase access to ADRD services in low resource settings.